Environmental Influences on Child Health Outcomes in the Northern Plains Safe Passage Study Cohort

Project Summary This overall purpose of this supplement application is to investigate participant, investigator and institutional review board member perspectives on return of individual results to participants. The results from this study will further the goals and activities of the parent grant, PASS ECHO Environmental Child Health Outcomes (5UH3OD023279-05). The overarching aim of the PASS ECHO study is to assess the impact of prenatal and early life exposures on long term child development. To accomplish this objective, the study utilizes a unique cohort established through the Prenatal Alcohol in SIDS and Stillbirth (PASS) Network (NICHD U02- HD045935), to provide a wealth of prenatal and infant data that can inform health outcomes during childhood such as, neurodevelopment, neurophysiology, and asthma, particularly among rural and American Indian youth and families. The PASS ECHO study is part of the Environmental Child Health Outcomes (ECHO) program, a national initiative that brings together thirty-one grantees from across the country to form a longitudinal cohort of approximately 50,000 children.

Public health relevance
Project Narrative This overall purpose of this supplement application is to investigate participant, investigator and institutional review board member perspectives on return of individual results to participants. The results from this study will further the goals and activities of the parent grant, PASS ECHO Environmental Child Health Outcomes (5UH3OD023279-05). Approximately, 3300 participants currently eligible for the PASS ECHO study will be invited to participate in this study.